Oxytocin Neurotransmission Overcomes Sleep Apnea-Related OIRD Hypersensitivity

This proposal seeks to uncover the biological basis for why sleep apnea patients are more sensitive to opioid-
induced respiratory depression (OIRD) - the primary cause of death due to opioid overdose. Clinically, there
is a pressing need for new therapeutics to counter respiratory depressive effects of opioids without interrupting
their pain-killing actions and without causing unwanted withdrawal effects. We recently discovered that
oxytocin, an analgesic and anxiolytic hormone and neurotransmitter produced in a major apnea-sensitive
respiratory arousal hub, the paraventricular nucleus of the hypothalamus (PVH), can prevent and reverse OIRD
by the most lethal opioid fentanyl. Notably, opioid receptor blockade with Narcan (naloxone, NLX) and
intranasal oxytocin both improve symptoms of obstructive sleep apnea. Our concept is that sleep apnea
patients have deficient oxytocin neurotransmission caused by an excess of endogenous opioids. This would
explain why both blocking opioid receptors and supplementing oxytocin improve sleep apnea symptoms. Our
central hypothesis is that deficient oxytocin neurotransmission from the PVH to respiratory neurons leaves the
respiratory network unable to mount a sufficient ventilatory defense response to effectively combat OIRD. This
oxytocin deficiency is modeled as an adaptive response to sleep apnea that prevents hyperventilation that
would otherwise result from tonic hyperactivity of hypoxia-sensitive carotid body chemoreceptors. Tonic
chemoreceptor activity is a well-recognized response to sleep apnea that contributes to development of
hypertension. Our working model holds that adaptive upregulation of PVH endogenous opioids by sleep apnea
becomes maladaptive when sleep apnea patients take an analgesic or illicit dose of opioid, leading to OIRD
hypersensitivity. According to our model, PVH endogenous opioid upregulation constitutes Hit #1 in a double-
hit scenario. Administration of exogenous opioid (i.e., fentanyl) constitutes Hit #2, triggering exaggerated
OIRD. Specific aims test the extent to which experimental upregulation of PVH endogenous opioids is sufficient
in normoxic mice to mimic OIRD hypersensitivity in mice exposed to our chronic intermittent hypercapnic
hypoxia (CIHH) model of SA. We will also investigate mechanisms whereby oxytocin receptor signaling
occludes the inhibitor action of opioids on respiratory neurons while also testing whether fentanyl CIHH OIRD
hypersensitivity is normalized by PVH opioid receptor blockade, eliminating Hit #1. Studies will further define
the contribution of endogenous PVH opioids in masking sleep apnea-related respiratory hyperdrive and in
blunted oxytocin excitation of respiratory neurons. Opto- and chemogenetic excitation and inhibition studies
will reveal the capacity of acute and prolonged excitation and inhibition of PVH oxytocin neurons to produce
exaggerated OIRD in normoxic mice and mitigate OIRD hypersensitivity in CIHH mice. Findings will yield new
translational information about a powerful oxytocinergic neural circuit previously unknown to opioid
resuscitation research and reveal new targets to prevent sleep apnea related OIRD hypersensitivity.

Public health relevance
The opioid epidemic is one of the most challenging public health crises of our time and sleep apnea patients are among the most vulnerable to suffer fatal opioid overdose. The focus of this proposal is two-fold: (1) identify the failing neurocircuitry that underlies sleep apnea-related hypersensitivity to opioid-induced respiratory depression and (2) address the clinical need for treatments that counter central opioid-induced respiratory depression without interrupting the pain-killing action of opioids and while avoiding central withdrawal effects. This research will advance our understanding of novel targets that can improve the clinical safety of opioids, especially in those most at-risk for their lethal consequences.